LEAD AND OTHER NEUROTOXINS AS RISK FACTORS FOR AMYOTROPHIC LATERAL SCLEROSIS

Neurodegenerative diseases pose an increasing challenge to public health as the population ages. Amyotrophic lateral sclerosis (ALS) is a neurod- egenerative disease of the motor system. Its etiology is essentially unknown, but environmental neurotoxins may be involved. A case-control study of ALS has been conducted to investigate the role of cumulative lifetime exposure to lead; other neurotoxins studied include mercury, solvents, and pesticides. Field work is now complete; 110 ALS cases, 30 clinic controls, and 270 population controls have been enrolled. Lead exposure was assessed in three ways: by measuring bone lead using x-ray fluorescence, an innovative noninvasive technique; with blood lead measurements; and using a structured in-person interview. Preliminary analyses showed that blood and bone lead were strongly correlated; both increased exponentially with age, but neither was associated with gender. Both were associated with occupational exposure to lead. After adjusting for age and gender, both blood and bone lead levels were higher in cases, and cases were more likely to have occupational exposure to lead. Further analyses will be conducted to confirm these findings and explore the effects of other neurotoxins. In addition, dietary antioxidant intake will be evaluated as a protective factor and as a modifier of other exposure-disease relationships. Polymorphisms in genes involved in xenobiotic metabolism or associated with ALS will also be studied, using PCR and RFLA, so that gene-environment interactions can be evaluated. Elucidation of the role of the environment in ALS may contribute to measures for prevention of this devastating disease and may in addition provide a paradigm for future studies of other neurode- generative diseases.